AVOIDABLE MORTALITY FROM CANCERS IN BLACK POPULATIONS

The work to be provided under this project is to circumvent barriers to primary prevention and secondary prevention that Blacks face for specific cancer sites. Specifically to: 1) Identify key factors that contribute to avoidable mortality, 2) implement intervention; and 3) identify prototype approaches to the reduction of avoidable mortality for wide-spread dissemination.